UofL RBL Operations, Workforce Development and Pandemic Preparedness Research

SUMMARY (OVERALL):
The University of Louisville Regional Biocontainment Laboratory (RBL) is operated by the University Center for
Predictive Medicine for Biodefense and Emerging Infectious Diseases (CPM). The RBL is a regional resource
that facilitates translational research to develop diagnostics, prognostics, therapeutics and vaccines to mitigate
biodefense and emerging infectious disease threats. Our Center operates the only BSL-3 and ABSL-3 facilities
currently operating in the Commonwealth of Kentucky. The CPM mandate is to prepare for and respond to public
health emergencies, such as the COVID-19 pandemic.
The broad, long-range objectives and goals of the University of Louisville (UofL) CPM RBL are:
1. To offer state-of-the-art research services to the regional and national biomedical research community to
learn from past pandemics and biological warfare experiences and effectively predict and mitigate future
emerging infectious disease threats.
2. To manage, maintain and operate the UofL RBL to serve the national and regional need for biocontainment
facilities suitable for research on Risk Group 3 pathogens and other biothreats.
3. To follow a philosophy of continuous improvement in BSL-3 and ABSL-3 work practices and to ensure that
all personnel who need to access BSL-3 and ABSL-3 containment laboratories are appropriately trained and
prepared to serve the national and regional need for biocontainment research professionals.
To achieve these aims we propose to establish three collaborative Cores. The Facilities Management
Maintenance and Operations Core (FMMO Core) is responsible for ensuring that the facility is always available
to meet the research and emergency preparedness mission of the RBL. The BSL-3 Practices and Workforce
Development Core (BSL-3PWD Core) formalizes our mentor-mentee training plan to ensure our laboratory is
staffed with BSL-3 research professionals who are proficient at biocontainment research professionals. This core
responds to the reality that response to rapidly emerging public health emergencies like COVID-19 is limited by
the number of available BSL-3 trained and experienced research professionals. Our Pandemic Preparedness
and Response Integrated Research Core (PaPR Core) responds to the substantially increased requests for our
BSL-3 research services by organizing an integrated full-service BSL-3 research support function to support
investigator needs. These cores will work in unison to achieve the CPM mission: to prepare for and respond to
public health emergencies like the COVID-19 pandemic.

Public health relevance
NARRATIVE (OVERALL): The University of Louisville Regional Biocontainment Laboratory (RBL) is a regional resource that facilitates translational research to develop diagnostics, therapeutics and vaccines to mitigate biodefense and emerging infectious disease threats. We propose to establish three cores that will work in unison to achieve the RBL mission to prepare and respond to public health emergencies like pandemics. The cores will be responsible for facility management and operations; for training laboratory workers in safe BSL-3 work practices; and for operating a full-service research support function for scientists who need to use the RBL.